Finding the way: Sensory adaptation during bacterial mechanotransduction

Abstract
Sensory adaptation is a short-term memory process by which a signaling system returns to its
pre-stimulus level despite ongoing exposure to the input signal. Although well-characterized in
bacterial chemotaxis, little is known about how adaptation operates in the other bacterial signaling
systems. A better understanding of how adaptation operates in these systems will provide new
fundamental knowledge and could identify new therapeutic approaches. We focus on
mechanosensing, which is critical for surface colonization and infection in Pseudomonas
aeruginosa (PA), a leading cause of multi-drug resistant nosocomial infections and a significant
health threat. PA uses the Pil-Chp mechanosensing system to transduce a mechanical signal that
drives twitching motility and cAMP production to modulate a virulence program upon surface
contact. How adaptation functions in this system, or mechanosensing in general, is unexplored.
We propose to dissect the mechanism and role of adaptation in the Pil-Chp system because (i)
The core enzymatic machinery of the mechanosensory adaptation system, the methylating
enzyme PilK and demethylating enzyme ChpB, are conserved but its regulation appears to be
distinct from the E. coli chemotaxis system; (ii) This system affords the opportunity to understand
how adaptation is deployed in response to surface contact; and (iii) The Pil-Chp system
contributes to virulence in a murine model of acute pneumonia, demonstrating its relevance to
human PA infections. We discovered that PilK acts as a methylase and ChpB acts as a
demethylase for the PilJ chemoreceptor to control the two outputs. Unlike in chemotaxis, the
methylase and demethylase exhibit inverse spatial localization. Our studies support a model in
which the PilK methylase localizes to the lagging pole, where the PilJ chemoreceptor would be
methylated and poised to be activated. In contrast, the ChpB demethylase is recruited to the
leading pole by interactions with the response regulator PilG. PilG is required for coordinating
TFP extension and retraction at the leading pole. This localization would lead to temporally and
spatially restricted PilJ demethylation at the leading pole. PilJ activity would be dampened,
potentially facilitating PilG relocalization to the lagging pole and reversals. Thus, sensory
adaptation in the Pil-Chp system is fundamentally different from adaptation in E. coli chemotaxis
in that it uses temporal AND spatial cues. We will test this hypothesis as follows: Aim 1. Link
PilJ methylation states to PilJ activity and outputs. Aim 2. Determine how the response
regulator PilG regulates the ChpB demethylase. Aim 3. Test whether the PilK methylase is
regulated by MapZ, a c-di-GMP binding protein, to link twitching and flagellar motility.

Public health relevance
Project relevance Pseudomonas aeruginosa is an environmental bacterium that is a leading cause of hospital acquired infections. Antibiotic resistance is rampant in P. aeruginosa, leading to limited therapeutic options. This grant seeks to understand how this bacterium responds to rapidly changing environments, which may lead to new therapeutic approaches to treat human infections.